Overcoming Neurogenic “Meta-Inflammation” to Promote Recovery After Spinal Cord Injury

The singular goal of most spinal cord injury (SCI) research programs is to repair the injured spinal cord and restore locomotor
function. Unfortunately, restoration of walking is a low priority for most SCI individuals 1. In addition to impaired mobility, SCI
causes slow and steady pathological changes in organ systems throughout the body. Failure to recognize and treat multi-
organ system pathology as a standard of care may explain why survival rates have not improved for SCI patients (relative to
able-bodied individuals) over the past 30 years 2. Emerging data indicate that after SCI, the loss of sympathetic tone and the
development of aberrant spinal autonomic reflexes that control immune organs (e.g., spleen) and the major organs that control
metabolism (e.g., liver, adrenal gland, muscle, adipose tissue and gut) cause immune dysfunction and multi-organ pathology.
Thus, mitigating the onset and downstream consequences of post-injury dysautonomia could improve immune and metabolic
homeostasis. Since immune and metabolic processes are normally tightly coupled and are essential for life 3,4, it is likely that
most, if not all, co-morbidities that affect SCI individuals (e.g., spontaneous infections in lung or skin, impaired wound healing,
non-alcoholic fatty liver disease (NAFLD), chronic depression, atherosclerosis, type 2 diabetes, fatigue and anxiety), can be
explained by impaired immunometabolism. Experiments in this proposal are designed to study SCI as a disease of the entire
body and will test the overall hypothesis that post-injury dysautonomia breaks neuro-immune homeostasis creating a state of
“neurogenic meta-inflammation”. This proposal is an integration of currently funded NINDS R01 grants and new ideas. All
experiments and concepts will build on my lab's past successes using both “macroscopic” (systems and networks) and
“microscopic” (cells to molecules) tools to study the pathophysiological significance of neuro-immune interactions. Just as
recent NIH initiatives have emphasized that cures for human brain disease are likely to arise from better understanding of
brain networks or circuits, rather than defects in a single brain region, a cure for SCI is unlikely to originate from a focus only
on repairing the injured spinal cord.

Public health relevance
The singular goal of most spinal cord injury (SCI) research programs is to repair the injured spinal cord and restore locomotor function. Unfortunately, restoration of walking is a low priority for most SCI individuals. In addition to impaired mobility, SCI causes slow and steady pathological changes in organ systems throughout the body. Failure to recognize and treat multi-organ system pathology as a standard of care may explain why survival rates have not improved for SCI patients (relative to able-bodied individuals) over the past 30 years. Experiments in this proposal are designed to study SCI as a disease of the entire body and will yield novel data that will ultimately promote recovery of function and quality of life (QoL) after SCI.